Hematopoietic Stem Cell-based CAR Macrophage for Alzheimer's Disease

Abstract
Alzheimer’s disease (AD), characterized by amyloid beta (Aβ) plaque accumulation, remains a
formidable challenge due to limited therapeutic interventions. Despite recent FDA approvals, Aβ targeting
antibodies fail to significantly impact the clinical progression of cognitive decline and the treatment is
associated with significant side effects. Recognizing these limitations, our project proposes a novel
therapeutic approach leveraging the versatility and potency of Chimeric Antigen Receptor (CAR) technology,
primarily known for its success in cancer treatment. We aim to develop a hematopoietic stem cell (HSC)-
based CAR-Macrophage (CAR-M) therapy targeting Aβ aggregates while simultaneously reducing central
nervous system (CNS) inflammation, a critical factor in AD pathology. Our preliminary work with CAR therapy
against HIV demonstrates the potential for long- term efficacy, safety, and CNS trafficking of CAR-modified
cells, laying the groundwork for this innovative AD treatment. The project is structured into two phases: the
R61 phase focuses on developing and optimizing Aβ- targeting CAR-M for in vitro efficacy against Aβ
aggregates and inflammation reduction, and investigate the safety and CNS trafficking of HSC-based CAR-
M in vivo. The R33 phase aims to evaluate the short- and long- term efficacy of this therapy in mouse models
of AD, assessing its impact on amyloid plaques, neuroinflammation, and behavioral outcomes. By combining
the expertise of leaders in CAR therapy and AD research, this project represents a groundbreaking step
towards a potentially transformative treatment for AD, addressing both the pathological hallmarks and the
inflammatory environment contributing to disease progression.

Public health relevance
Project Narrative Our project aims at developing a novel Alzheimer's disease (AD) treatment using Chimeric Antigen Receptor (CAR) technology to develop hematopoietic stem cell-derived CAR-Macrophages (CAR-M) targeting amyloid beta (Aβ) plaques and reducing CNS inflammation, addressing the limitations of current therapies. Building on promising preliminary work in CAR therapy against HIV, the project will proceed in two phases: optimizing Aβ- targeting CAR-M and evaluating its efficacy in AD mouse models, focusing on plaque reduction, inflammation mitigation, and behavioral outcomes. This collaborative effort combines CAR therapy and AD research expertise, aiming to transform AD treatment by targeting its pathological and inflammatory components.